DELINEATION OF PATTERNS OF INHERITANCE

The purpose of this project is to clinically delineate new genetic disorders and to define patterns of inheritance in the large number of them in order to provide genetic counseling.